Oral-intestinal microbial translocation and colonization

PROJECT SUMMARY
Small-intestine microbes play pivotal roles in human health, and can affect (and be affected by) factors such as
probiotics, diet, drugs, supplements, and botanicals. Probiotics, including engineered probiotics, act in the small
intestine and may support or compete with commensals and pathogens, as well as improve micronutrient
absorption. In contrast, an altered SI microbiota has been implicated in impairing the efficacy of supplemental
nutrition. Despite these important roles, studies of the human small-intestine microbiome are challenging
because this region of the gut is difficult to access and because the sequencing tools used to analyze stool
microbiomes are inappropriate for host-dominated mucosal samples. Critical gaps include knowing which
microbes colonize the human small-intestine mucosa, where those colonizers originate from, and which microbial
genes and/or environmental features enable them to persist there. These gaps must be addressed in humans
because mouse models of the small-intestine microbiome are severely hampered by coprophagy. One long-
standing hypothesis is that microbes from the oral cavity transit the acidic gauntlet of the stomach and colonize
the small intestine. However, this hypothesis remains contentious and unproven because it is difficult to
differentiate colonizers from dead microbes and endoscopies are known to introduce oral contaminants.
The primary goal of this R21 exploratory study is to document the first definitive observation of oral microbes
translocating and colonizing the SI. To accomplish this goal, we will utilize a combination of two innovative
technologies we have optimized for studying host-rich microbiomes: (1) quantitative sequencing for measuring
the absolute abundances of microbial taxa and differentiating it from contamination and (2) a microbial
enrichment method that enables the construction of high-quality microbial metagenome-assembled genomes
directly from host-rich samples. Identifying a definitive example of live oral-derived microbes colonizing the SI
will open new avenues for more complete characterization of human intestinal microbes and a framework for
further study of the relationship between oral and small-intestine microbial communities. For example, prebiotics
intended to nourish beneficial small-intestine microbes and probiotics can be rationally designed to not
inadvertently promote growth of oral pathobionts. Similarly, probiotic strains can be engineered to better compete
with the oral pathogens capable of colonizing the small intestine and also take advantage of administered
prebiotics. Ultimately, the findings from this R21 will improve the microbiome field’s understanding of how oral
microbes can affect interventions such as specialized diets, drugs, prebiotics, probiotics, dietary supplements,
and botanicals.

Public health relevance
PROJECT NARRATIVE Colonization of the small intestine by microbes from the oral cavity has been hypothesized as a key contributor to the pathogenesis of many human diseases, but numerous challenges have prevented this phenomenon from being observed. This exploratory R21 project leverages a unique study design and several innovative technologies, providing a rare opportunity to document colonization of the SI by oral microbes. This study would justify and technologically enable additional studies needed to fill critical knowledge gaps in oral-intestine microbial interactions and how oral microbes affect various interventions (diet, drugs, probiotics, supplements, botanicals, etc.) in the context of human health and disease.